Airway microbiome and age 6y asthma phenotypes in 2 diverse multicenter cohorts

PROJECT SUMMARY / ABSTRACT
Bronchiolitis is the #1 cause of hospitalization in US infants, with ~130,000 hospitalizations
annually. Small cohort studies (n<210) suggest that 40-50% of infants hospitalized with
bronchiolitis will later develop asthma. The greatest challenges for developing primary
prevention strategies for this large group of children (indeed, all children) are the very early
identification of modifiable risk factors and the heterogeneity of asthma. The 35th Multicenter
Airway Research Collaboration (MARC-35) study (U01AI-087881; Camargo, PI) is a 17-center
prospective cohort study that completed enrollment of 921 hospitalized infants with bronchiolitis
in 2014. In this diverse cohort (53% African-American or Hispanic), investigators have collected
biospecimens, including nasal swabs at the index hospitalization (median age 3 months) and at
an age 3y exam (R01AI-114552; Camargo, PI). Follow-up data include biannual parent
interviews and medical records to age 5 years, with ~90% follow-up to date. This UG3/UH3
application would: 1) extend the largest severe bronchiolitis cohort in the world (e.g., through an
age 6y in-person exam to diagnose and phenotype asthma), and 2) build on our local MARC-43
cohort of 120 healthy infants by adding 600 healthy infants from four diverse sites (total n=720).
Both cohorts undergo similar procedures (e.g., serial nasal swabs during early childhood). Our
overarching hypothesis is that airway Moraxella abundance is associated with increased risk of
childhood asthma, and our pilot data are supportive. In Aim 1, we will investigate the relation of
the airway microbiome in early infancy to risk of age 6y asthma among infants with severe
bronchiolitis (MARC-35). In Aim 2, we will do the same but among healthy infants (MARC-43).
In Aim 3, we will investigate the relation of longitudinal patterns of the airway microbiome (e.g.,
infancy, age 3y, age 6y) to risk of childhood asthma in the two cohorts combined. In a subset of
200 children (100 from each cohort), we will use whole genome shotgun (WGS) sequencing to
examine the relations of bacterial species and metabolic potential in early infancy to risk of
asthma. For all 3 Aims, we will examine if associations differ by asthma phenotype (e.g., allergic
asthma). The investigators are NIH-funded researchers working in an outstanding research
environment. The proposed project is innovative and, by providing a strong evidence base for
the future development of targeted microbiome interventions, advances research on the primary
prevention of asthma. Moreover, the two racially/ethnically-diverse cohorts will provide the
ECHO Consortium with comprehensive data on demographics, development, environmental
exposures, genetics, and outcomes from two already-harmonized, multicenter U.S. studies.

Public health relevance
PROJECT NARRATIVE In two racially/ethnically-diverse cohorts – MARC-35 with 921 infants originally hospitalized with bronchiolitis, and MARC-43 with 720 healthy infants – the investigators will examine the relation of nasal airway microbiome in early infancy to risk of developing childhood asthma. The project will advance the primary prevention of asthma and provide two already- harmonized, multicenter U.S cohorts for the ECHO Consortium.